Using Augmented Reality To Make Cardiac Ablation Procedures Simpler and Safer

Abstract The goal of this SBIR FastTrack application is to deliver an augmented reality (AR) platform technology that displays an interactive 3D cardiac hologram to make ablation procedures simpler and safer. World-wide, cardiac ablations are used as therapy for ~1 million arrhythmia patients every year. There is, however, significant skill required to perform these procedures and only a handful of cases can be performed per facility, per day. By using AR to provide an interactive, shareable, patient-specific cardiac model, we will make ablation procedures simpler. By simplifying the procedure, physician performance is improved by allowing them to more quickly and thoroughly understand electroanatomic relationships, making complicated ablation procedures more tractable and improving efficiency and efficacy. Shortening procedures, reducing anesthesia time, radiation exposure and time wearing lead aprons will make procedures safer.

Public health relevance
Narrative Cardiac ablation procedures are used to treat patients with abnormal heart rhythms. The goal of this application is to use augmented reality to provide physicians who perform cardiac ablation procedures with a patient-specific hologram of the heart and the instruments that they are using inside of it. By improving the visualization of this information and empowering the physician with direct control of the model, we will make these procedures both simpler and safer.